Pharmacokinetics-Based DNA-Encoded Library Screening

PROJECT ABSTRACT
This R00 proposal seeks to expand the space of druggable protein targets through the
development of novel analytical technology that will guide the design of next-generation, non-Lipinski molecular therapeutics and diagnostics. Cyclic peptides, which are not drug-like (i.e., Lipinski-like), hold great promise for addressing undruggable targets, especially protein-protein interactions (PPIs).
However, the larger molecular mass and more complex secondary structures result in unpredictable and almost
always low cell permeation, significantly blunting their utility as drug candidates and even as preclinical tool
compounds in cells. Rarely, a cyclic peptide will exhibit anomalously high permeation. However, insufficient data
exist to uncover the rules dictating permeation because high-throughput measurements of cell permeation
simply do not exist. In K99 phase, a high-throughput in vitro permeation assay compatible with DNA-encoded
combinatorial library (DEL) screening was developed and miniaturized to the microfluidic droplet scale. In this
proposal, the permeation assay will be applied to screen DELs to identify the species that efficiently permeate
membrane bilayers. The permeable macrocycle hits will be further validated in a cell-based permeation assay
that was also developed in K99 phase and will be further investigated in the project. The large screening data
sets will reveal relationships between permeability and structure, especially for molecules of beyond the Rule of
5 (bRo5), which will be further analyzed using machine learning. With these and other empirically derived
models of macrocyclic peptide pharmacokinetic properties in hand, we may finally be able to move such nonLipinski molecules from the lab to the clinic at scale. This proposal will significantly enhance the PI's career
development and advance her goal of becoming a tenured professor and a leader in analytical assay and tool
development to understand cell membrane permeability. San Diego State University offers an ideal research
environment, boasting renowned experts in chemistry and chemical biology and fostering a collaborative
intellectual community. Through this plan, the PI will engage in activities essential for achieving independence,
including establishing a robust research program, honing grantsmanship skills, networking, and preparing for
tenure evaluation. The proposed plan will facilitate the PI's scientific and professional growth, positioning her
for future R01 funding success.